Fostering knowledge translation of neuroplasticity-targeted interventions for chronic pain management using advanced meta-analytic methods and statistical learning

SUMMARY
Chronic pain is one of the most prevalent diseases and the leading cause of disability worldwide. Given
its high inter-patient variability to response to treatment, ineffectiveness of available pain medication to
completely relieve chronic pain, and unequal availability of pain treatments for underrepresented
populations, it remains a burdensome, difficult to treat condition. In this context, neuroplasticity-targeted
interventions (NTIs) are being investigated as a potential solution for the current issues with chronic
pain. They are a group of diversified therapies that modulate neuroplasticity of pain-related pathways
through bottom-up or top-down approaches. Although significant effects of electricity-based techniques
such as transcranial direct current stimulation (tDCS) have been evidenced for pain reduction in
different chronic pain conditions, there is high inter-trial variability regarding these results with different
combined NTIs. Therefore, given the hard-to-treat nature of chronic pain and the unknown optimal
combination of NTIs, this proposed project suggests a multiphase optimization strategy to assess the
direct and indirect comparative effects of NTIs (and their components) in chronic pain, and to develop
a treatment hierarchy using living Bayesian network meta-analyses (Aim 1). These meta-analyses will
provide the framework for the development of supervised machine learning models to predict analgesic
response to NTIs in chronic pain (Aim 2). Aim 2 will be carried out with the use of secondary, clinical,
and neurophysiological data from 14 clinical trials with 669 patients to implement multilevel modeling
considering different chronic pain predictors shared among different chronic pain conditions and types
of interventions. Both evidence bodies (network meta-analyses and predictive models) will be deployed
in an open access web-based platform, which will facilitate the constant update (monthly) and data
sharing to a broad user population. My expertise and background in meta-research, data science,
neuromodulation, and chronic pain research will allow me to fulfill this project’s aims with no foreseeable
obstacles. Moreover, I will be working with collaborators from Spaulding Neuromodulation Center and
University of Sao Paulo that have been significantly involved in studies conveying the promising effects
of NTIs for the reduction of chronic pain. Therefore, the R03 award will provide preliminary data for
further funding application and promote the precision pain management approach via data sharing and
fusion approaches.

Public health relevance
Project narrative This project is significant since chronic pain is a major global health problem, a leading cause of disability, with just partially effective treatments associated with major adverse events. Thus, there is a need to develop non-pharmacological, non-invasive, and fully home-based interventions for chronic pain. An alternative is interventions that target the brain plasticity. Our proposal aims to assess the effects of these alternative neuroplasticity-targeted interventions in chronic pain, and to develop models to predict the response to the treatment based on artificial intelligence.